Administrative Core

ADMINISTRATIVE CORE: PROJECT SUMMARY
The Virginia Commonwealth University Massey (VCU) Cancer Center (MCC) Administrative Core centrally
operationalizes and promotes the MCC vision, mission, goals, and strategies by providing the overall planning
and management of a full range of administrative services supporting the best practices in cancer research
administration. The MCC Administrative Core is led by the Associate Director for Administration, Michelle K.
Lin, MBA, who directs a team of 39 highly qualified and experienced individuals contributing to strategic
planning, implementation, and evaluation efforts for all Center-sponsored initiatives. Collectively, the members
of the MCC Administrative Core are directly responsible for MCC’s $41.7M annual operational research budget
and more than 95,575 ft2 of assignable research and administrative space and coordinates all aspects of
membership engagement activities for 147 faculty members. Essential Administrative Core functions include
managing the National Cancer Institute-funded Cancer Center Support Grant (CCSG); managing consistent and
effective communications, across multiple in-person and virtual platforms, with all internal and external
constituents; providing administrative and business management support for MCC’s shared resources;
overseeing the membership review and research productivity metrics; administering pilot research award
mechanisms; and enhancing the information technology capabilities for collecting and reporting data as required
for management and evaluation. Major new initiatives supported since the last CCSG renewal include organizing
and developing MCC’s 2021-2025 Strategic Plan; facilitating the re-alignment of two former MCC basic research
programs into one Cancer Biology Program; leading and/or directly supporting the recruitment and start-up
packages for 38 new cancer research faculty; contributing to the development and submission of more than 120
research proposals to extramural funding agencies, resulting in $32M in funded multi-year awards; organizing
and supporting the establishment of several new advisory entities aligned with MCC’s Community-to-Bench
framework to ensure community voices are synergistically heard alongside VCU-based leadership; supporting
the modeling of the new VCU Health Cancer Service Line governance and operations structure and MCC
institutional funds flow model; and instituting new and revised policies for MCC membership, cancer relevance
for grants and publications, and charters for all MCC committees/boards to ensure appropriate diversity and
inclusion representation. Of particular note, the Administrative Core also led the development and
implementation of three new offices spearheading areas for Center growth: the Office of Diversity, Equity, and
Inclusion; the Office of Community Outreach and Engagement; and the Office of Cancer Research Training and
Education Coordination. With the recruitment of numerous experienced cancer research administrators to the
team, the Administrative Core is well positioned to foster a premier community-focused and engaged Cancer
Center leading the nation in cancer research and the promotion of cancer health equity.